Medical Genetics Training Grant

The overall goals of the T32 Postdoctoral Training Program in Medical Genetics at Johns Hopkins are to
recruit and educate physician-scientists who have the potentials to become leaders in the field of Genetic
Medicine. Our program is designed to expose trainees to all facets of modern medical genetics and genomics
extending from research programs to patient care. This postdoctoral training experience emphasizes mentored
research in medical genetics and genomics, and prepares trainees for a career in academic medicine. Since the
majority of our trainees are physicians, we utilize a physician-scientist training model to bridge the gap between
genetics research and clinical medicine.
Johns Hopkins provides leadership in the categorization and mapping of inherited traits, the application
of genomic and computational methods to the identification and understanding of genes and their roles in human
diseases, and in clinical research, diagnosis, and treatment of Mendelian disorders and multifactorial disorders
with significant genetic contributions. The McKusick-Nathans Department of Genetic Medicine (DGM), the home
of this training program, oversees the clinical, educational, and research activities in human and medical genetics
at the Johns Hopkins University School of Medicine.
This T32 postdoctoral training program in medical genetics is in its 44th year of operation with supports
from NIGMS. The mentored research training is integrated into a medical genetics residency, which is designed
to optimize the utilization of the rich clinical and research resources and training environments at Johns Hopkins
and support the career development as physician scientists for our trainees. Clinical genetics training is followed
by a period of intensive research training with maximally protected research time supported by this T32 training
grant. The research training is under the auspices of a carefully selected research mentors and monitored by a
research committee. After a successfully completion of this program, trainees are eligible for certification by the
American Board of Medical Genetics in clinical genetics and possess strong research experiences and expertise
to embark on independent career as physician-scientists. Our training program has an outstanding track record
of educating physician-scientists who have made and continue to make substantial contributions to the field of
medical genetics. Over the last 10 years, our trainees had an average 4.5 peer-reviewed publications from T32
supported training and the vast majority (>80%) of our graduates took research-centered or research-related
positions at academic institutions. URM trainees are well represented in our training program. We have now
optimized integrated curriculums that combine clinical and research training in medical genetics, expanded
diversified trainee populations and training resources by developing combined programs with pediatrics, internal
medicine, MFM, REI, and a training consortium with NHGRI, and established structured research fellowships to
support the interests and career goals of individual trainees to advance their careers as physician scientists.

Public health relevance
Project Narrative The T32 postdoctoral training program in Medical Genetics at the Johns Hopkins University trains physicians and scientists in the application of genetic principles to understand the causes and mechanisms of inherited diseases in humans. Through mentored research training, T32 trainees acquire experiences and expertise in translating genetic information from bench to bedside with the primary goal of improving health outcomes in patients with genetic and genomic disorders.